Chemical Exposure Facility Core

PROJECT SUMMARY - Chemical Exposure Facility Core (CXC)
The Chemical Exposure Facility Core (CXC), directed by Kim Anderson, supply passive sampling devices
(PSDs) and analytical services to advance environmental health science. Members of the EHS CC will apply
PSDs and our analytical methods to provide decision support for stakeholders such as community
organizations, manufacturers, regulators, legislators, NGOs, health care providers, and pharmaceutical firms.
Accurately assessing the breadth of a person's exposures to environmental toxicants is central to the challenge
of studying environmental health effects. The CXC offers directly analytical methods for over 1,500 organic
chemicals and facilitates additional chemical analyses through our additional campus resources. The lack of
low cost, easy-to-use personal sampling technology hinders epidemiological studies, especially in
disadvantaged populations. Over the last several years with OSU and EHS Core Center investments have built
personal sampling wristband technology with unique analytical methods. We made these investments,
specifically because Public Health faculty and Community partners were enthusiastic about its broad potential
to fill a key gap in Public Health. Our passive wristband sampler was developed to provide a relevant,
quantifiable assessment of chemical bioavailable exposure. The passive sampling platform including
wristbands will form the foundation for providing new and critical resources for Center researchers to measure
organic chemicals that are a crucial component of the chemical exposures. Over 1,500 volatile and semi-volatile
organic chemicals can be quantified. Through our core, in partnership with the Integrated Health Sciences
Facility Core and Community Engagement Cores, we enhance and stimulate many partnerships and
collaborative efforts using the analytical methods and passives sampling/wristband platform as the
gravitational force that bring researchers, public health experts, community organizations and citizens
together. Passive samplers naturally stimulate collaborative research relationships and interdisciplinary teams.
The Core will provide center investigator and study participants and their communities, novel and appropriate
data visualization of our wristband data. The CXC will extract and analyze chemical mixtures, thereby enabling
EHS CC members to measure concentrations of environmental toxicants.